RESPONSE OF CUTANEOUS CELLS TO INJURY FROM EXPOSURE TO TOXIC ENVIRONMENTAL AGENT

Study the response of cultivated human cells to damage by irradiation, chemical agents, oxygen toxicity, temperature and mechanical injury. Study cells from individuals having heritable diseases.